AMINO ACID TRANSMEMBRANE TRANSPORT AND PROTEIN METABOLISM IN HUMANS

Investigates the regulation of amino acid and protein metabolism in humans by means of nutritional and pharmacological intervention. Determines the in vivo rate of transmembrane amino acid transport, the rate of intra-muscular protein synthesis and protein degradation using stable isotopic tracer methods. Separate arms focus on the response to insulin or amino acid supplementation at rest or during the recovery phase after a strenuous bout of exercise.